REPLICATION AND PATHOGENESIS OF HEPATITIS B VIRUS

DESCRIPTION: Dr. Ou proposes to study three aspects of the HBV pathogenesis and its replication cycle: core protein phosphorylation, C gene transcription controls, and the role of the X gene in replication. Aim 1 will evaluate the model that core protein phosphorylation blocks virus assembly. Virions will be analyzed for phosphorylation; virus infection will be reconstituted with core proteins mutated to block phosphorylation at specific residues. Viral regulation, packaging efficiency, and virion production will be analyzed. Aim 2 deals with transcriptional regulation of the core gene, which actually encodes both precore and core proteins by initiating from two different transcription start sites. The study will focus on a critical regulatory site that binds COUP, HNF4, PPAR-RXR, and when mutated, HNF1. Preliminary studies have also characterized an upstream negative regulatory element (NRE) that binds RFX1/MDBP1 and MIBP1. The NRE will be further analyzed in Aim 3. Finally, Aim 4 will evaluate whether the X protein activates cell cycle-dependent genes to support HBV regulation. For these studies, a transgenic mouse will be constructed to incorporate a functional HBV genome, but with a defective X gene.